Targeting APOBEC3A-induced genetic heterogeneity and drug resistance in bladder cancer

PROJECT SUMMARY/ ABSTRACT
Every five minutes, a new patient is diagnosed with urothelial carcinoma (UC) in the United States, resulting in
the death of 18,000 patients annually. Nearly all patients with advanced UC will develop resistance to systemic
treatment. Intratumoral heterogeneity (ITH) is a major contributor to treatment resistance by increasing the
chance for resistant subclones to emerge. However, genetic ITH is currently not druggable and not considered
in therapeutic decision-making, thus worsening drug-resistant patient phenotypes. The fundamental knowledge
gap regarding genetic drivers of ITH impedes the development of effective therapeutic strategies to prevent and
eliminate drug resistance. Our long-term goal is to define targetable mechanisms of ITH and treatment resistance
to develop an effective precision strategy to achieve cures in patients with advanced UC. The overall objective
is to define targetable mechanisms by which APOBEC3A-mediated ITH drives drug resistance and identify
strategies to eliminate UC cells with APOBEC3A activity. Our central hypothesis is that APOBEC3A-induced
cytidine deamination drives genetic ITH leading to the emergence of therapy-resistant UC clones and, in
so doing, simultaneously creating unique targetable vulnerabilities. This hypothesis was formulated based
on our published work and strong preliminary data showing that APOBEC3A expression in isogenic UC cell lines
and patient-derived organoids drives genetic ITH. We found that APOBEC3A-induced, de novo mutations in the
PIKC3A-AKT-MTOR signaling hub drive the resistance to erdafitinib, an FGFR3-inhibitor (FGFR3i) approved for
UC treatment. Our preliminary data also revealed that APOBEC3A-induced double-stranded DNA breaks are
preferentially repaired by the microhomology-mediated end-joining (MMEJ) pathway and that targeting the
critical MMEJ mediator, polymerase theta (Polθ), is synthetically lethal in APOBEC3A-expressing clones. The
rationale is that identifying targetable mechanisms by which APOBEC3A-induced ITH drives drug resistance and
developing strategies to eliminate APOBEC3A-expressing UC cells will improve cure rates for patients. We will
test our hypothesis by pursuing two specific Aims. Aim 1: Identify targetable mechanisms by which APOBEC3A-
induced mutational ITH drives treatment resistance in UC. Aim 2: Identify synthetic lethal strategies to target UC
tumors with APOBEC3A-induced DNA double-strand breaks. Aim 1 will use longitudinal clonal barcoding and in
vitro and in vivo laboratory evolution to identify targetable APOBEC3A-driven kinase hubs that mediate FGFR3i
resistance and validate them in patient samples from FGFR3i clinical trials. Aim 2 will use genetic and
pharmacologic inhibition of Polθ in APOBEC3A-expressing UC models and a co-clinical trial of patient-derived
UC organoids and xenografts to identify clinical biomarkers of response to APOBEC3A-MMEJ synthetic lethality.
The approach is conceptually and technically innovative, creating a new paradigm for eliminating treatment-
resistant cancers. Impact: Completion of the proposed research will establish APOBEC3A as a genetic driver of
treatment resistance and enable synthetic lethal approaches to increase cure rates.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will transform our understanding of APOBEC3A-induced genetic intra-tumoral heterogeneity as a driver of targeted therapy resistance in bladder cancer. Successful completion of this project will 1- Identify targetable kinase hubs downstream of APOBEC3A-induced intra-tumoral heterogeneity to treat advanced bladder cancers that developed FGFR3 inhibitor resistance 2- Define novel synthetic lethal strategies to eliminate cancer cells with APOBEC3A activity. These advances will increase cure rates for patients with advanced bladder cancer.